The Impact of Discrimination on Anthropometric Outcomes: An Analysis of the Adolescent Brain Cognitive Development (ABCD) Study

Project Summary
Obesity disparities in children and adolescents have persisted for decades. The reasons for these disparities
are not fully understood, despite research into factors such as diet, physical activity, and socioeconomic
position. Discrimination has been implicated as a social determinant for obesity. While discrimination is
understood as a multidimensional construct that operates at multiple levels and in different social contexts, the
association between multiple forms of discrimination and obesity among youth remains understudied, as well
as the underlying mechanisms by which discrimination may affect obesity. This study aims to define the
relationship between multiple forms of discrimination and obesity using longitudinal data from the Adolescent
Brain Cognitive Development (ABCD) study, in order to increase the efficacy of prevention efforts and
treatment to reduce obesity and obesity disparities. The study will assess the association between different
forms of discrimination (neighborhood and interpersonal) and the growth trajectory of anthropometric outcomes
(i.e., BMI and waist circumference), examine the role of discrimination in explaining racial/ethnic disparities in
anthropometric outcomes, investigate the extent to which obesity-related health behaviors mediates the
relationship between discrimination and adiposity, and evaluate the potential buffering effect of psychosocial
resources (e.g., family support and positive school environment). Overall, this study has the potential to inform
the optimization of existing clinical and place-based interventions aimed at reducing obesity by highlighting the
importance of addressing discrimination and identifying the context and most at-risk groups that can benefit
from these interventions to reduce health disparities.

Public health relevance
Project Narrative Racial/ethnic disparities in obesity among youths persist. The proposal aims to elucidate the influence of both neighborhood and interpersonal discrimination on the risk of obesity among children and adolescents. The study will provide a comprehensive examination for how discrimination impacts youth, shedding light on (1) the behavioral processes involved, (2) protective factors that may mitigate the risk, and (3) the broader implications for racial/ethnic disparities in obesity that can be extrapolated to the entire U.S. population.